Task A22: Development of a new system for scaled-up culture and propagation of Pneumocystis

This contract provides in vitro testing of potential anti-bacterial agents and anti-fungal agents, maintenance of bacterial and fungal stocks, and the development of related assays.